Molecular basis of ILK-mediated cell adhesion

The long term goal of this renewal proposal is to gain deep mechanistic understanding of integrin-mediated cell
adhesion that occurs in virtually every human life process. Integrins are a family of 24 heterodimeric (α/β)
transmembrane receptors differentially expressed in cells and tissues. Being expressed in inactive form, integrins
are activated via a distinct process called “inside-out” signaling where cellular stimulation elicits intracellular
signals to induce global conformational change of the receptors to bind extracellular matrix (ECM) ligands.
However, for cells to firmly adhere to ECM, or change shape, or migrate as required by many physiological
processes, the activated integrins need to further communicate with intracellular cytoskeleton (“outside-in”
signaling) via the formation of large protein complexes called focal adhesions (FAs). Understanding the
mechanism of such bi-directional signaling phenomenon has been the central topic of cell adhesion biology ever
since the discovery of integrins in middle 1980s. While much has been learned about the integrin “inside-out”
signaling, how FAs are assembled to mediate the integrin “outside-in” signaling still remains highly elusive due
to its complex and dynamic nature. To this end, we have been focusing on integrin-linked kinase (ILK) - a major
FA regulator and initiator of the integrin outside-in signaling. ILK was long thought to function as a Ser/Thr kinase
to phosphorylate integrin β cytoplasmic tail (CT) to trigger signaling. However, our recent studies challenged the
longstanding dogma by showing that ILK is a non-catalytic pseudokinase yet can transmit mechanical signaling
linking integrin to actin to regulate cytoskeleton reorganization and cell adhesion. Interestingly, ILK was also
shown to mediate multiple important biochemical signaling events yet much of the published data were
misinterpreted by considering ILK as a kinase with exact mechanisms being unknown. This proposal will
rigorously address this issue with a central hypothesis that an ILK-centered heterotrimer called IPP
spatiotemporally recruits distinct signaling enzymes to integrin adhesion sites and trigger signaling. In Aim1 we
will investigate a longstanding puzzle of ILK-mediated Ser/Thr kinase AKT1 signaling. Aim2 will elucidate the
mechanism of ILK-mediated small GTPase Rac1 signaling. Aim3 will develop potent ILK inhibitor that targets at
the pseudoactive site of ILK to regulate the IPP stability, which will help to deepen the understanding of the ILK
signaling events. Overall, our proposed studies reflect a strong momentum of our program towards establishing
a new paradigm of how ILK acts as a multi-functional pseudokinase to spatiotemporally regulate integrin outside-
in signaling events to promote dynamic cell adhesion and diverse adhesion-dependent physiological processes.
These studies, along with the development of potent ILK inhibitor, may also transform the diagnosis and
treatment of ILK-associated diseases such as heart failure and cancer.

Public health relevance
The adhesion of cells to extracellular matrix is fundamentally important for many physiological processes such as heart development, tissue regeneration, and wound healing. Such adhesion process is controlled by integrin- linked kinase (ILK) and it dysregulation has been linked to the progression of numerous diseases such as heart failure and stroke. Our proposal aims at determining the basic mechanism of the ILK function and its inhibitor development, which will not only help understand cell adhesion at normal and disease states of our body but also transform the diagnosis and treatment of ILK-mediated diseases.